Elucidating the role of an essential transcription factor in SWI/SNF -mutant rhabdoid tumors

Abstract
Mutations in genes that encode subunits of the SWI/SNF chromatin remodeling complex are observed in nearly
25% of all cancers. Because of this, understanding the mechanisms that lead to cancer progression following
SWI/SNF perturbation has great relevance for our understanding of cancer. Rhabdoid tumors (RTs) provide an
excellent model for the study of SWI/SNF loss as these genomically simple, but lethal cancers of early childhood
are driven by the biallelic inactivation of a single SWI/SNF encoding tumor suppressor gene, SMARCB1.
Through the Pediatric Cancer Dependency Project, 16 RT cell lines from various tissues of origin were submitted
by our lab to the Broad Institute for genome-wide CRISPR-Cas9 knockout screening as a part of the Cancer
Dependency Map (DepMap). Due to the unique nature of RTs as diploid cancers with relatively low mutational
burdens that are driven by the specific loss of SMARCB1, CRISPR screening in these cancers can be leveraged
as a highly powerful tool. By comparing genetic dependencies in these 16 RT cell lines to over 1100 other
cancers in DepMap, dependencies that are unique to SMARCB1-deficient cells can be systematically identified
and characterized. This proposal focuses on a transcription factor encoding gene which is a unique dependency
in RT cell lines. I propose that studying the function of this poorly characterized transcription factor will provide
critical insight into the dysregulated cellular environment that results from SMARCB1 loss. Whilst little studied,
the available literature suggests that this transcription factor cooperates with a repressive chromatin-regulatory
complex. I have confirmed that this factor is essential in RTs, interacts with this repressive complex, and co-
localizes with this complex on chromatin. However, instead of repressing transcription, my preliminary work
shows that this factor is a robust transcriptional activator, a previously undescribed function. I hypothesize that
this transcription factor exerts a critical activating function in RTs by antagonizing the activity of its
repressive binding partners. Further, I propose that this function is uniquely essential in cells that have
lost the ability to activate genes through SMARCB1-containing SWI/SNF activity. Through two aims, I will
investigate this transcription factor’s mechanism of function and the role of SMARCB1 loss in promoting cellular
dependence on its expression. Using a targeted structure-function approach in conjunction with genome-wide
approaches, I will uncover the relationship between this transcription factor and its binding partners and elucidate
the effects of disrupting this relationship on chromatin and transcription. Additionally, using cell line models
pioneered by our lab to efficiently add and remove SMARCB1, I will study this protein’s function with direct
respect to SWI/SNF status. In pursuit of this project under the mentorship of Dr. Charles Roberts, I will build the
necessary technical, computational, and professional skills to become an independent investigator focused on
chromatin dysregulation in cancer by the end of my training period.

Public health relevance
Project Narrative Mutations in chromatin regulatory genes frequently cause cancer. This is true of the highly lethal childhood rhabdoid tumor, which is caused by the loss of SMARCB1, a subunit of the SWI/SNF chromatin remodeling complex. I have discovered that the disruption of a normally inconsequential transcription factor kills rhabdoid tumor cells and I aim to investigate why this occurs and whether this finding can be leveraged as a therapeutic opportunity for SMARCB1-deficient cancers.